Establishing Robust Characterization of Novel Therapeutic Responses and Disease Models of Necrotizing Enterocolitis

PROJECT SUMMARY
Necrotizing enterocolitis (NEC) is a life threating intestinal disease in premature infants, with high mortality rates
of 20-40%. To date, there are no approved therapies available for NEC. To address this challenge, we have
shown that human-derived placental stem cells (hPSC) can ameliorate both the dysregulated inflammation and
damaged epithelium in NEC. Based on the potent paracrine signaling mechanism of hPSC, we have identified
hPSC extracellular vesicles (hPSC-EV) as a promising cell-free therapy with distinct advantages in translational
potential. However, the efficacy of the hPSC-EV therapy compared to hPSC therapy is unclear. Elucidation of
both the repaired and unaffected NEC-associated expression profiles following therapy is also needed to fully
optimize a hPSC-based therapy approach. With similar pathology to medically-managed NEC in human infants,
the rat pup model of NEC is well-suited to identify disease-associated cellular and transcriptional changes in
NEC disease and with hPSC-based treatment. Human enteroid model systems are also often employed to
investigate intestinal diseases and therapeutics for improved translation to the human disease. However, a NEC
enteroid model system has not yet been rigorously validated for the ability to recapitulate NEC disease features
of the epithelium. Based on promising preliminary data, we now seek to address these 2 challenges in NEC by
defining the efficacy of hPSC-EV therapy, determining the cellular and transcriptional changes in NEC disease
and therapy repair, and establish a novel human NEC enteroid monolayer model system. We hypothesize that
integrated characterization of in vivo NEC pathogenesis, in vivo hPSC-based therapeutic responses, and an in
vitro human NEC model system will elucidate unique cell-specific expression profiles of NEC disease and repair
pathways and validate the retention of the NEC epithelial-associated expression profile in a novel in vitro human
NEC enteroids-based model system. The aims of this application reflect an integrated study of in vivo and in vitro
NEC disease and therapeutics to: (1) assess the efficacy of hPSC-EV as compared to hPSC therapy, (2) identify
cell population andl cell-type specific expressional profiles during NEC disease and hPSC-induced repair, and
(3) establish human NEC enteroids-derived model systems as a high-throughput model system for human
disease translation. In Aim 1, we will determine the efficacy of hPSC-EV therapy and utilize scRNAseq to profile
shifts in cell populations and identify novel expression profiles within these cells in both disease and repair. In
Aim 2, we will utilize bulk RNAseq to determine the ability of 3D enteroids and 2D monolayers derived from
resected human NEC tissue to recapitulate known in vivo NEC expression profiles. Combined the proposed
studies will advance our understanding of targetable repair pathways in NEC and provide a human disease
model to improve clinical translation. With strong, supportive preliminary data and impactful proposed studies,
this study has a high likelihood of establishing success for building a robust translational foundation. These
studies will inform our future translational efforts investigating advanced therapeutic strategies in human NEC.

Public health relevance
PROJECT NARRATIVE Necrotizing enterocolitis (NEC) is a life-threatening intestinal disease in premature infants that currently has no clinically-approved therapies or robust model systems for high throughput therapeutic investigations. Our studies assessing the length-scale of NEC, from early damage onset to established NEC disease to repair, have elucidated previously unknown pathogenesis and reparative pathways as well as having demonstrated that placental stem cell (hPSC)-based therapies are a multi-faceted approach that can ameliorate NEC damage. This proposal seeks to use RNAseq approaches to 1) assess hPSC-extracellular vesicles as an advanced cell-free therapy, 2) define cell population and their associated cell-type specific expression profiles that change during in vivo NEC pathogenesis and therapy-induced repair, and 3) establish a novel in vitro human NEC enteroid- derived model platforms as a high throughput translational NEC model.